Improving needs among older adults: the ICUconnect 2 primary palliative care RCT

Millions of older adults receive care in intensive care units (ICUs) annually. However, the quality and accessibility of ICU-based palliative care is highly variable across hospitals and clinicians, due in part to specialists’ limited workforce and geographic inconsistency. Furthermore, there are few evidence-based interventions designed to help ICU clinicians provide primary palliative care themselves.
To address these gaps, we developed an innovative mobile app-based primary palliative care intervention called ICUconnect. ICUconnect facilitates families’ and patients’ self-report of actual palliative care needs across all core domains of palliative care quality, provides ICU clinicians with a scalable digital infrastructure for coordinating consistent and personalized needs-targeted care, and provides a variety of informational supports relevant to each user’s role. In a recent single-center cluster RCT with 111 patient-family member dyads (U54 MD012530), ICUconnect significantly improved unmet needs and goal concordance of care compared to usual care control.
What is now needed is a multicenter RCT to test the intervention’s efficacy and simultaneously ascertain potential challenges to broader implementation. Therefore, we propose to test ICUconnect vs. usual care control among 350 patient-family member dyads with elevated baseline levels of unmet palliative care need in a 4-site network (Duke, Medical University of South Carolina, University of Alabama at Birmingham, Columbia). The specific aims are to: (1) Test the efficacy of ICUconnect vs. usual care control in improving palliative care needs and other person-centered outcomes including psychological distress, (2) Determine participant characteristics associated with a greater treatment response using a heterogeneity of treatment effects approach, and (3) Ensure off-the-shelf intervention readiness for implementation using a mixed-methods integration of qualitative analysis of semi-structured trial participant interviews and quantitative RE-AIM implementation framework-informed trial data.
This project is likely to make a strong clinical impact because it fills notable gaps in the rigor of prior research, targets populations often omitted from past palliative care trials, and tests an innovative intervention that could be immediately used in any healthcare setting at population scale, is easily adaptable to any language, leverages strong preliminary data, and includes new concepts in care delivery and outcomes measurement. The likelihood of success is high because of the team’s expertise in clinical trials, critical care, palliative care, geriatrics, and health technology.

Public health relevance
Narrative Millions of older adults receive care in intensive care units (ICUs) annually. However, because there are few evidence-based interventions designed to help ICU clinicians themselves provide primary palliative care to patients, we developed ICUconnect—a mobile app-based intervention for clinicians and family members—and found in a pilot trial that it reduced palliative care needs. This proposal aims to test the intervention’s efficacy in a diverse population and to understand how other hospitals can best implement it in the future